DIETARY REGULATION OF ARACHIDONATE LEVELS AND INFLAMMATION

Oxygenated derivatives of arachidonic acid (AA) produced by inflammatory cell act as potent mediators of inflammation and allergy. This study proposes: 1) that vegetarians who consume little preformed AA have lower AA in serum and cellular complex lipids; and 2) dramatic reductions in serum and cellular AA levels as well as eicosanoid biosynthesis can be achieved when AA and its metabolic precursors, such as linoleic acid, are largely removed from diets of omnivore volunteers.